Impact of Senolytics on Aged Vaccine Responses

PROJECT SUMMARY
Despite widespread vaccination, influenza (flu) remains a leading cause of death among older adults.
Vaccination is the most effective way to prevent infectious disease. However, older adults have dysregulated
immune responses that reduce vaccine efficacy and leave them at risk for severe infection and death. Older
adults have reduced T cell proliferation, impaired B cell responses, and decreased antibody titers following flu
vaccination. Current methods to improve vaccine efficacy in older adults target singular deficits in immune
responses and fail to completely rescue responses. Vaccination requires a complex coordination of multiple
cell types and tissues; thus an approach that targets the overall biology of aging, in line with the geroscience
hypothesis, may be more appropriate for improving vaccine protection and immune responses in older adults.
Senescent cell accumulation is a hallmark of aging and evident in various tissues with age. Although these
cells are characterized by a mostly irreversible state of cell cycle arrest, they remain metabolically active and
importantly, secrete a heterogeneous cocktail of inflammatory cytokines and chemokines that contribute to
tissue dysfunction and damage that is coined senescence associate secretory phenotype (SASP).
Accumulation of senescent cells and SASP create pro-inflammatory environments and have a causal role in
many age-related disorders. CD4 T cells and B cells, the main cells responsible for robust vaccination
responses, are extremely sensitive to their microenvironments. Thus, we propose that accumulation of
senescent cells and their SASP drive diminished vaccination responses with aging.
Importantly, drugs that specifically kill senescent cells, termed senolytics, have been developed and require
only intermittent administration to eliminate senescence cells and mitigate the SASP. The safety and efficacy
of senolytics have been shown in mouse studies and can alleviate a range of age-related diseases. Human
pilot studies have supported their safety and clinical utility in certain pathologies. However, the impact of
senolytics on vaccination responses in aged populations has not yet been examined. The overall hypothesis
in this proposal is that senescent cells and the SASP play a causal role in impaired flu vaccination
responses with aging and that pharmacological clearance of senescent cells will improve vaccination
responses. We will test this hypothesis by treating young and aged mice with senolytic drugs prior to
vaccination. We will utilize two different vaccination methods, recombinant flu nucleoprotein to induce
protective immunity and adjuvanted inactivated flu to induce neutralizing immunity, and then infect mice with flu
to interrogate both cell-mediated and humoral vaccination responses. Additionally, we will test our hypothesis
in human cells by determining how senescent cell conditioned media impact human T and B cells responses in
culture. These approaches will allow us to examine the role of cellular senescence in impaired vaccination
responses with aging and investigate the translational utility of senolytic drugs as a pre-vaccination adjuvant.

Public health relevance
PROJECT NARRATIVE Older adults have reduced immune responses to vaccination that leave them more vulnerable to infectious diseases, such as influenza. The overall hypothesis in this proposal is that the age-associated accumulation of senescent cells and the senescence associated secretory phenotype (SASP) are the main drivers of diminished vaccine responses with aging. To assess this we will 1) pharmacologically eliminate senescent cells in mice via senolytic drugs prior to influenza vaccination and determine immunomodulatory effects on cell- mediated and humoral responses to vaccination and influenza infection challenge; and 2) determine translational impact via in vitro analyses of human T and B cell responses when exposed to senescent media.